Mechanistic dissection of eukaryotic protein biogenesis and degradation pathways

Abstract
My lab currently has two main areas of interest: 1) a new chaperone system (eFOLD) that enables biogenesis
of eukaryotic translation elongation factor 1 alpha (eEF1A); 2) endoplasmic reticulum (ER) and peroxisome
degradation by selective autophagy. Errors in eEF1A biogenesis result in rapid degradation by the
ubiquitin-proteasome system (UPS) thus making protein degradation a natural link between the two areas.
Both eFOLD and selective autophagy are controlled by distinct stress responses (e.g. heat shock vs. amino
acid starvation) but jointly serve as eﬀectors of protein homeostasis (proteostasis). Both areas raise similar
questions regarding substrate selectivity: How does a speciﬁc eFOLD chaperone co-translationally recognize
an aggregation-prone region of eEF1A nascent chains? How is terminally misfolded eEF1A recognized for
degradation by the UPS? What signals on damaged or unwanted organelles are detected by speciﬁc
autophagy receptors to orchestrate encapsulation of organelle targets into autophagosomes? To answer
these questions, we are dissecting biogenesis and degradation mechanisms that select substrates of grossly
diﬀerent sizes, respond to distinct physiological cues, and have widely diﬀerent temporal dynamics. Using
yeast and human cell culture in parallel, we are exploring conserved aspects of eFOLD and selective
autophagy mechanisms shared by each species, as well as species-speciﬁc adaptations. Broadly speaking,
our projects spawn from identiﬁcation of missing factors by genetic screening or biochemical puriﬁcation but
all seek a deep mechanistic understanding of mutant phenotypes through biochemical reconstitution with
puriﬁed components and protein structure-function analysis. Along this path, we iteratively test our
hypotheses by genomics, quantitative cell microscopy, and theoretical modeling approaches.

Public health relevance
Narrative Our lab studies how human cells help one of their most abundant proteins achieve its correct three-dimensional shape; this protein enables production of all other proteins and is blocked by a drug with pre-clinical efficacy against SARS-CoV-2. We also study how human cells adapt to stress by remodeling their intracellular membrane compartments by a quality control process that staves-off neuronal degeneration with age.